Population Sciences

The goal of the Population Sciences Program (PS) of the Stanford Cancer Institute (SCI) is to conduct high- impact transdisciplinary and translational research across the cancer continuum aimed at improving detection through screening, reducing cancer incidence, morbidity and mortality, and improving cancer outcomes. The PS achieves this goal by promoting and facilitating innovative multidisciplinary observational and interventional research on cancer that will impact public health and guide clinical practice and health policy. PS members are nationally and internationally recognized clinical and population scientists with a broad range of unique strengths in epidemiology, genetics, quantitative modeling, bioinformatics, use of novel technologies, behavioral science, lifestyle (physical activity, diet, tobacco control, sleep), and clinical and palliative care interventional trials, and community health and prevention research. The program’s overarching research priorities include reducing the cancer burden in the population of SCI’s catchment area. PS members’ research addresses the following Specific Aims: Aim 1: Conduct research on cancer etiology, risk prediction, screening, and genetic testing; Aim 2: Investigate the impact of cancer treatment and prognostic factors on outcomes; and Aim 3: Conduct intervention research to reduce cancer risks and improve outcomes. The PS has 39 members, of whom 31 are supported by peer-reviewed funding totaling $14.0M, including $7.4M from the NCI, $5.0M other cancer-relevant NIH support, and $1.6M from other peer-reviewed support. During the current funding period, PS members published 1,130 peer-reviewed manuscripts. Of these, 22% are intra- programmatic, 23% are inter-programmatic, 96% are multi-institutional, and 18% are in journals with an impact factor of 10 or higher. Support from the SCI has been instrumental in promoting both intra- and inter- programmatic collaborations of PS members, recruiting new faculty members, and enabling preliminary research through innovation grants that lead to externally funded projects. PS members also strive to train the next generation of cancer prevention researchers. In the future, the PS will further expand and focus on research in genetic risk profiling and assessment, outcomes and survivorship research across the life course, and health services and implementation science, and will develop and submit a T32 training grant in genetic epidemiology and population sciences.